MODULATION OF ALCOHOL REINFORCEMENT

This project is directly concerned with the learning and motivational processes underlying ethanol-seeking behavior. The long-term goal is to improve our understanding of the behavioral and neurobiological process that contribute to the etiology, maintenance, elimination and relapse of alcoholism. The general experimental strategy involves study of ethanol's motivational effects in oral self-administration and place conditioning tasks using animals. Special emphasis will be placed on the learning that results from the predictive relationship between environmental stimuli and exposure to ethanol rewarding or aversive effects. The central organizing hypothesis of this research is that ethanol-predictive stimuli have a direct impact on ethanol's motivational effects and that they are importantly involved in motivating or directing ethanol-seeking behavior, including the phenomenon of relapse after extinction or abstinence. One set of proposed experiments will examine effects of ethanol-predictive stimuli on conditioned hyperthermia and barpressing in a signaled self-administration procedure using rats and mice. Variables of interest include: Sucrose concentration, CS-ethanol overlap, ethanol access duration and conditioned reinforcement. The second set of studies will determine effects of ethanol-predictive stimuli on conditioned place preference and aversion in rats and mice. Variables of interest include: dose, number of trials, CS-ethanol interval, genotype, and route of administration. The final series of experiments will study the role of ethanol-predictive stimuli in extinction, relapse and relapse prevention. In addition to improving our understanding of ethanol-predictive stimuli, these studies will shed new light on apparent species differences in ethanol s motivational effects, and on findings that ethanol-predictive stimuli can acquire opposing motivational effects within the same species. A better understanding of these issues is essential for using these animal models to study neurobiological and genetic contributions to alcoholism. This project should help focus future research on the neurobiological mechanisms of ethanol-seeking behavior, aid in the development of beneficial treatments for alcohol abuse, and facilitate identification of effective relapse prevention strategies. These studies could prove to be especially useful in the evaluation of putative pharmacotherapies intended to reduce alcohol craving and in the design of behavioral interventions to decrease ethanol-seeking behavior.